Developmental Origins of Metabolic Disorders

Abstract
The postdoctoral Pediatric Endocrinology and Diabetes Training Program at the University of Michigan is
designed to recruit and provide high quality research training in one of two major tracks, Basic Science or
Clinical Investigation & Epidemiology to qualified candidates. Now on its 15th year, the theme of the Program is
developmental programming of disorders of glucose metabolism. The program is organized to complement the
established training program in clinical pediatric endocrinology for M.D.s, and for basic scientists pursuing a
career in endocrine related research, by providing 2 years of intensive postdoctoral training using a closely-
mentored research training program individually structured for each trainee. The program is actively supported
by 14 faculty from 11 UM Departments/Schools, all with extensive research and mentoring experience within
their respective areas of expertise. The Program also includes an extensive didactic component tailored to
each trainee’s educational background and research interests. Trainees initiating Basic Science research
complete a 3-month course designed to expose them to a variety of state-of-the-art techniques, as well as to
skills in performing hypothesis-driven, controlled research studies. Trainees in Clinical Investigation &
Epidemiology choose between Outcomes & Epidemiology or Clinical Research. They complete courses
leading to either a Master of Public Health in Biostatistics & Epidemiology or a Master of Science in Clinical
Research Design & Statistical Analysis. In addition to the formal curriculum, trainees attend weekly clinical and
research seminars, receive instruction preparing and delivering oral presentations, and instruction in ethical
conduct of research. Mentored research is supported the Medical School resources including the Centers of
Comprehensive Diabetes Research, Nutrition Obesity Research, Organogenesis, Human Growth and
Development, Comprehensive Metabolomic Center, Molecular & Behavioral Neuroscience Institute and the
Michigan Institute for Clinical and Health Research. To optimize each trainee’s potential for development of a
successful academic career, trainees are required to submit abstracts to national meetings, submit a first-
authored research manuscript, and apply for individual grant funding. Expansion of our Program will help
alleviate the critical shortage of successful Pediatric Endocrinologists and Pediatric Physician-Scientists.

Public health relevance
Narrative Research training is integral to the future of biomedical advancement and the needs of academic centers to provide an environment that integrates the vision of research to deepen our understanding of biology, stimulate interdisciplinary research teams, and reshape clinical research that in turn accelerates medical discovery and improves health. The present proposal will train medical doctors (MDs) and scientists (PhDs) to study the origins of disorders of glucose metabolism in children (illnesses such as obesity, pre-diabetes, diabetes) using basic or clinical science investigation and applying these to accelerate medical discoveries to improve children's health, prevent development and/or ameliorate severity of metabolic diseases. This approach will undoubtedly improve the health of the US population.